Computational Modeling of Interoceptive Perception across the Psychosis-Spectrum

Project Summary/Abstract
Distressing psychosis symptoms (i.e., hallucinations and delusions), exist on a spectrum from subclinical to
those observed in diagnosed individuals, occur in an astonishing 5-8% of the general population, and are often
accompanied by disability, reduced social functioning, and cognitive impairments. Mechanisms underlying
psychosis-spectrum symptoms remain unclear, limiting development of targeted treatments. A new approach
focuses on internal body states (e.g., heartbeats, temperature) that shape experiences of self, others, and the
world, and are essential to adaptive behavior. Interoception encompasses the detection, integration, and
interpretation of internal body states, which appears disrupted and critically understudied in psychosis. Clinical
exemplars include mismatched behavior (e.g., wearing a parka in hot weather), reality distortions (e.g., believing
back pain is from a tracking device), and loss of body ownership (e.g., perceiving external control). Interoceptive
accuracy tasks reveal poor detection of internal body states across the psychosis-spectrum; however, this cannot
be separated from cognition. To move beyond descriptive work and limitations, the current study non-invasively
manipulates internal body states in a predictive coding paradigm. Further, computational modeling dissects
interoceptive predictive coding into subprocesses and disentangling relationships with psychosis symptoms
versus cognition to provide translational insights that may inform future treatment targets.
Predictive coding is a neuro-cognitive framework, where ‘prior beliefs’ allow for predictions about incoming
sensory information for efficient responding. A prediction error results from a discrepancy between the ‘prior
belief’ and sensory information, which should update the belief for future adaptive behavior. Therefore, the brain
makes sense of the world through iterative hypothesis testing, by comparing ‘prior beliefs’ (top-down
predictions) with sensory information (bottom-up stimuli). This framework has provided valuable insight to
exteroceptive perception (e.g., auditory, visual) in psychosis-spectrum samples, where strong ‘prior beliefs’
dominate perception. Similarly, strong interoceptive ‘priors’ may drive poor interoceptive accuracy in psychosis,
and be a critically untested process contributing to both false perceptions (hallucinations) and formation of false
beliefs (delusions) that fail to reflect the environment. Computational models of predictive coding can dissect
interoceptive perception into higher- and lower-level subprocesses, including weighting of ‘prior beliefs’,
adaptability, and behavioral consistency, to test differential relationships with key clinical features of psychosis.
Thus, the current study will move the field forward by 1) testing a hypothesis of strong interoceptive ‘prior beliefs’
within the psychosis-spectrum, and 2) investigating differential relationships for subprocesses of interoceptive
predictive coding with psychosis symptoms versus cognition. Together, the proposed research and training plan
establish a critical foundation integrating cognitive science theory and computational methods with basic
interoception research to advance our understanding and treatment targets for distressing psychosis symptoms.

Public health relevance
Project Narrative Disrupted interoception (i.e., detection, integration, and interpretation of internal body states) may be a critical process in distressing psychosis symptoms (i.e., hallucinations and delusion). Manipulation of internal body states during predictive coding experiments is necessary to move beyond descriptive research, overcome limitations of existing tasks, and elucidate how interoceptive perception is related to key clinical features in the psychosis-spectrum. Using an individual differences design, computational modeling will dissect interoceptive predictive coding into subprocesses and disentangle their relationships with psychosis symptoms versus cognition to provide translational insights that may inform future treatment targets.